Defining the degradative and inflammatory responses to mitochondrial damage in astrocytes.

PROJECT ABSTRACT (SUMMARY)
Astrocytes, the most abundant cell type in the brain, contribute to neuroinflammation seen in neurodegenerative
diseases like Parkinson’s disease (PD). Mitochondrial dysfunction is also a hallmark of PD, and occurs in both
neurons and astrocytes. However, the consequences of mitochondrial dysfunction in astrocytes are not well
understood. As accumulating data link mitochondrial damage to onset of inflammation, it is essential to our
understanding of PD to elucidate astrocytic responses to mitochondrial damage. Here, I will (1) define a pathway
astrocytes use to clear damaged mitochondria (PINK1/Parkin mitophagy), and (2) identify inflammatory signaling
cascades resulting from mitochondrial damage in primary astrocytes. In PINK1/Parkin mitophagy, PTEN-induced
kinase 1 (PINK1) and ubiquitin E3 ligase Parkin coordinate assembly and phosphorylation of ubiquitin chains on
damaged mitochondria. Autophagy receptors, which facilitate autophagosome biogenesis, are recruited to this
ubiquitin. Our lab demonstrated that the NF-κB essential modulator (NEMO) protein is also recruited to Parkin-
assembled ubiquitin chains. This is a novel mechanism for initiation of NF-κB signaling, a major innate immunity
pathway. Using oxidative phosphorylation (OXPHOS) inhibitors as mitochondrial damaging agents, I found that
NEMO recruitment to damaged mitochondria occurs in cortical murine astrocytes ex vivo. Prolonged treatment
results in heightened transcription of NF-κB-associated cytokines TNF-α and Il6, and TNF-α upregulation is
ameliorated by NF-κB inhibition. Studies in HeLa cells suggest the autophagy receptor p62 is recruited to
mitochondria alongside NEMO. I observe both p62 upregulation and recruitment to damaged mitochondria in
astrocytes, suggesting p62 participates in astrocytic mitophagy. About 50% of p62 localizes to phospho-ubiquitin,
indicating phosphorylation of ubiquitin may drive p62/NEMO recruitment. However, it is unclear if p62 is
necessary for mitophagy in astrocytes, how it influences NEMO recruitment, and whether NF-κB is the major
pathway activated. Based on my initial data, I hypothesize p62 is required for mitophagy and promotes NEMO
recruitment to ubiquitin chains (Aim 1), and that NF-κB is the major inflammatory pathway activated (Aim 2a,b),
resulting in secretion of neurotoxic signals that promote neurodegeneration (Aim 2c). In Aim 1, I will test whether
knocking down p62 hinders mitophagy in astrocytes. I will also perform in vitro reconstitution assays with purified
protein to determine if the efficiency of NEMO recruitment to damaged mitochondria is increased by p62 and
phosphorylation of ubiquitin. In Aim 2, I will analyze bulk RNA-sequencing data from wild-type (WT) and PINK1
knockout astrocytes treated with OXPHOS inhibitors or a vehicle control. I will look at differential gene expression
related to inflammatory signaling and NF-κB, and validate sequencing results via an NF-κB inhibitor and qPCR.
Finally, I will compare the neurotoxicity of WT and PINK1 knockout astrocytes with and without OXPHOS inhibitor
treatment. This project will define how astrocytes clear damaged mitochondria and the inflammatory signaling
activated by this mitochondrial damage, which is critical to understand the role of astrocytes in PD pathology.

Public health relevance
Project Narrative Astrocytes are non-neuronal cells in the brain that heavily influence neuronal health, and that have been increasingly appreciated to play a role in neurodegenerative diseases like Parkinson’s disease. One key aspect of Parkinson’s disease is dysfunction of mitochondria in neurons and astrocytes; although this has been extensively studied in neurons, we do not understand how astrocytes clear damaged mitochondria or whether astrocytes that have sustained this type of damage release inflammatory molecules toxic to neurons. This project will address these questions, thus providing information about how astrocytes respond to mitochondrial damage that will help us understand astrocytic contributions to Parkinson’s disease pathology.